Clinical Core

Clinical Core
Stephanie S. O’Malley, Ph.D.
Abstract
The Clinical Core serves an important function as the central resource for the diverse CTNA projects and
pilots. The opportunity to fund a central core with a distinguished leader provides a programmatic method to
define needs and assign resources to address central issues. The central components of the Clinical Core
are oversight of subject recruitment, participant safety and clinical assessments in human studies, and data
management and biostatistical support for all Center projects. The Core also oversees the creation of a cross-
project “Core Database” for investigating phenotypes relevant to the CTNA and its mission. The specific aims
for this core are:
A. Centralized monitoring and recruitment of subjects to: 1) Enhance the efficiency of enrollment into each
project, including pilots; 2) Ensure the safety of participants and 3) Update the Principal Investigators (PIs),
the Steering Committee, the Program Advisory Committee, and the Data Safety Monitoring Board of
progress on the protocols.
B. Central oversight of assessments to: 1) Provide efficiency in training and assessment; 2) Maintain
consistency in the administration of assessments; 3) Enhance the ability of investigators to pool data
across studies; 4) Ensure that validated and current assessment tools are used; and 5) Support secondary
analyses utilizing core assessments from the Core database.
C. Central provision of data management and biostatistics support to: 1) Provide design and analytical
expertise to meet the goals of the CTNA scientific agenda; 2) Provide state-of-the-science methods for
data management; 3) Generate randomization lists and assess randomization implementation; 4) Interface
with specialized data analysis expertise related to particular technologies associated with the CTNA,
including genetics and imaging; 5) Prepare reports related to the progress of clinical studies for the Data
Safety Monitoring Board, FDA and NIH; 6) Provide statistical support for all investigators; and 7) Create
data structure and uploads required for the provision of data to the NIAAA Data Archive.